Scientific Working Group

Project Summary Scientific Working Group (SWG)
The HIV pandemic continues to pose significant challenges, with disparities in progress evident in the St. Louis
area and Missouri at large. Populations left behind from the benefits of effective prevention and treatment
interventions bear a disproportionate burden of new infections, morbidity, and mortality. Black men and women
are particularly affected, with alarmingly higher prevalence rates compared to their white counterparts.
Additionally, Missouri's rural regions face elevated risks of HIV outbreaks due to rising syndemics and limited
investments in public health. To address these urgent issues, the scientific working group (SWG) of the
Midwest Developmental Center for AIDS Research (D-CFAR), led by Drs. Michael Durkin and Dima Dandachi,
aims to establish a collaborative community involving academics, regional stakeholders, and community-based
partners. This collaboration will conduct pragmatic, community-engaged, and stakeholder-embedded research
targeted towards neglected populations affected by HIV. The project's success is rooted in two key ingredients:
a cohort of passionate emerging investigators from local universities, dedicated to innovative health care
delivery and harm reduction principles, and strong partnerships with community-based organizations and
regional public health agencies. The SWG will leverage these assets by facilitating regular interactions
between academics and practitioners, fostering idea exploration, and providing funding for academic-
practitioner partnerships. The proposed aims are as follows: Aim 1: Develop a multidisciplinary research
collaborative for neglected populations in the Missouri epidemic, comprising researchers, community-based
organizations, and public health practitioners. The collaborative will meet regularly, employing the Nominal
Group Technique to prioritize research ideas and foster a shared vision for impactful, pragmatic research that
can contribute to ending the HIV epidemic in Missouri. Aim 2: Establish a community-academic research
incubator to develop community and practitioner-led proposals for D-CFAR pilot funding mechanisms. The
research agenda generated in Aim 1 will serve as the foundation for future research aims. This incubator
program will provide support, mentoring, and coordination to turn ideas into tangible community-based
research projects, focusing on partnerships between academic institutions and non-academic stakeholders.
The impact of the Neglected Populations SWG will significantly contribute to the overall goal of the CFAR to
enhance research infrastructure in the state. By prioritizing community-based research for neglected
populations, the SWG aims to create unique opportunities that combine the expertise of groups with
lived/practitioner experience in HIV treatment and prevention with that of academic medical center
researchers. This inclusive approach will lead to a substantial increase in novel research proposals and a
strengthened funded research base, ultimately advancing efforts to combat HIV and improve health services
for underserved communities.